Predoctoral and Postdoctoral Training in Alzheimer's Pathophysiology

We proposed creating a highly collaborative pre- and post-doctoral training program in the pathophysiology of Alzheimer’s disease and other related neoconservative disorders. Our program is dedicated on advancing pre- and post-doctoral fellows into independent research scientists at research intensive universities and health- related research laboratories. Our trainees will be mentored by members of the Mitchell Center for Neurodegenerative Diseases at the University of Texas Medical Branch – Galveston. Our highly collaborative faculty reach across multiple departments allowing them to employ a number of experimental approaches to the problems associated with Alzheimer's disease. Our training program incorporates cellular animal models, disease progression mechanisms and pharmacological manipulations, immunotherapeutic approaches targeting tau and amyloid oligomers, synaptic electrophysiology and, DNA damage and repair in neurodegeneration, genetics of synaptic development and degeneration, molecular mechanisms in cognitive resilience, and metabolic determinants of neurodegeneration. A strength of our training program is the investment UTMB has made in developing this highly collaborative team as demonstrated by our joint publications and funded grants. Our four pre-and three post-doctoral trainees will be closely mentored throughout their training. Our pre-doctoral trainees will be required to take several new courses devoted to the cellular signaling in neurodegeneration and the biochemistry and biophysics of amyloid proteins, while our post-doctoral trainees will participate in a certificate program in advanced biomedical research strategies. All trainees will participate in seminars, community building events, journal clubs and active collaborative research training. We have proposed a framework that will enable us to train and mentor both pre- and post-doctoral trainees on their way to becoming independent scientist to help address the Alzheimer’s medical needs of the country.

Public health relevance
Alzheimer's disease (AD) is the leading cause of dementia and imposes tremendous burdens on families, communities, and the health care system. Tragically, the population of Americans suffering from AD is expected to grow to 16 million by 2050. There is no cure, but insights into the pathophysiology of AD promises more effective treatments to ease symptoms, slow progression, and prevent disease. This is an application for the training of pre-doctoral and post-doctoral fellows in the area of Alzheimer's Disease (AD) related to neurodegenerative disorders pathophysiology.